Family Involvement in Treatment for PTSD (FIT-PTSD): A Brief, Feasible Method for Enhancing Outcomes, Retention, and Engagement

Although effective treatments for PTSD exist, high rates of treatment dropout and sub -optimal response rates
remain common. Incorporating family members in treatment represents one avenue for improving outcomes
and providing Veteran-centered care, and surveys of Veterans in outpatient VA PTSD care indicate that 80%
desire family involvement. The VA has invested many years and millions of dollars on the dissemination of
Cognitive Processing Therapy (CPT) and Prolonged Exposure (PE) for PTSD. A family-based intervention that
complements these two first-line treatments would capitalize on existing treatment infrastructure while also
potentially boosting outcomes and retention. Preliminary testing of the proposed Brief Family Intervention (BFI)
resulted in 50% less dropout from CPT/PE among Veterans whose family members received the BFI. There
was also a large impact on PTSD symptoms at 16 weeks (d = 1.12) in favor of the BFI group. The goal of this
study is to test the effectiveness of the BFI among a fully-powered sample. One hundred Veteran-family
member dyads (n = 200) will be recruited. Veterans will be beginning a course of usual-care CPT or PE at one
of two VA sites. Family members will be randomized to receive or not receive the BFI, a two -session
psychoeducational and skills-based protocol. PTSD symptom severity and treatment retention will be the
primary outcomes. Assessments will be conducted by independent evaluators at baseline, 6 -, 12-, 18-, and 26-
weeks. Veterans whose family members receive the BFI are expected to have lower dropout and a greater rate
of change in their PTSD symptoms compared to Veterans whose family members do not receive the BFI. If the
BFI is found to increase the effectiveness of and retention in CPT/PE, it will be a highly appealing option for
incorporating families into Veterans’ PTSD care.

Public health relevance
Incorporating family members into PTSD treatment may improve rates of retention in care and result in better outcomes. Surveys of Veterans seeking VA treatment for PTSD indicate that large majorities desire furher involvement of their family members in their treatment. Although several family-inclusive PTSD treatments exist, they require many sessions and are burdensome to Veterans, families, and clinicians. The Brief Family Intervention (BFI) is a brief adjunctive treatment designed to complement Cognitive Processing Therapy (CPT) and Prolonged Exposure (PE). Data from a small CSR&D-funded trial indicated that having a family member participate in the BFI resulted in 50% less dropout from CPT/PE among Veterans. If the proposed fully- powered trial of the BFI shows similar results, VA providers will have an appealing new option for incorporating families into Veterans’ care while continuing to provide the most strongly-supported EBPs for PTSD.